Antibody display libraries for precision screening of antibody immune responses to SARS-CoV-2

PROJECT SUMMARY/ABSTRACT This project will determine the antibody-based immune features in COVID-19 patients to accelerate the development of new medical interventions. SARS-CoV-2 causes asymptomatic or mild disease in many individuals, demonstrating that an effective human immune response can fully prevent disease. However, it remains unclear what immune response features are associated with protection from disease. To address this question, here we will analyze comprehensive antibody immune responses in COVID-19 patients and determine how the molecular features of antibody immunity correlate with COVID-19 symptom severity. First, we will immortalize antibody immune libraries from COVID-19 patient cohorts into yeast display libraries for comprehensive in vitro functional screening. B cell samples from COVID-19 patients will be isolated and emulsified as single cells for native antibody DNA recovery, and antibody genes will be transformed into a yeast Fab display platform for repertoire-scale antibody functional analyses. Antibodies will be screened for binding to the SARS-CoV-2 spike trimer, a dominant neutralization target, and also for inhibition of ACE2 binding to map neutralizing antibodies in human immune responses. We will also mine our renewable antibody immune libraries for broader features that may correlate with COVID-19 disease severity. We will investigate antibodies targeting broad SARS-CoV-2 antigens and epitopes, including multiple epitopes on the spike trimer protein (such as the receptor binding domain, RBD, the N terminal domain, NTD, and the S1 region) and internal viral proteins (e.g., nucleocapsid protein). We will also map the molecular features of single B cell responses (e.g. affinity, competition-based epitope mapping, and differential binding to different spike protein conformations) to comprehensively track anti-SARS-CoV-2 molecular immunity in a human cohort. We will analyze the genetic features of each antibody clone to help elucidate the balance of neutralizing vs. non-neutralizing antibodies as potential disease correlates. Finally, we will perform large-scale data mining of the antibody repertoires from each patient population to identify key molecular features that may distinguish mild and severe SARS-CoV-2 infections. These new molecular-scale correlates and potential biomarkers will improve basic and clinical understanding to advance COVID-19 preventions and therapies. We seek to reveal critical immune-based biomarkers of COVID-19 diseases severity and identify new potent antibody drug candidates to treat and prevent COVID-19.

Public health relevance
Project Narrative This project will apply new high-throughput immune profiling technologies to elucidate the features of effective Epstein-Barr virus (EBV) immune control. EBV causes a range of human diseases including infectious mononucleosis and several forms of cancer; however, limited EBV treatment options are available and no approved preventive EBV vaccines exist. Our long-term objective is to apply enhanced understanding of adaptive immunity to accelerate the rational development of new vaccines and therapeutics.